Cellular Mechanisms of Renal Interstitial Fibrosis

DESCRIPTION (provided by applicant): Progression of renal disease leads to common consequences including interstitial fibrosis, glomerulosclerosis, vascular narrowing, and renal failure, ultimately requiring dialysis or renal transplantation. The kidney myofibroblast is the cell type most responsible for matrix accumulation during renal fibrosis. Although there is a large amount of data on mechanisms of interstitial myofibroblast matrix synthesis late in the course of renal fibrosis, information on the earliest cellular events involving myofibroblast encroachment into the perivascular and interstitial spaces prior to matrix accumulation is lacking. Experiments are proposed to examine mechanisms of myofibroblast encroachment (migration and proliferation) in a model of accelerated renal fibrosis in which myofibroblasts first originate from perivascular and periglomerular regions. Our central hypothesis is: Activation of PDGFR-2 and TGF-beta receptor induces fibroblast migration and proliferation into the peritubular interstitium via Rho/ROCK modulated ROS generation and transduction of PI3-kinase/Akt, MAPK (ERK1/2) signaling pathways early during the progression of renal fibrosis. The following aims are set: Aim 1. NAD(P)H oxidase-derived ROS are involved in myofibroblast interstitial encroachment early during the course of kidney fibrosis; Aim 2. ROS-induced interstitial myofibroblast migration, proliferation and matrix synthesis is a consequence of PDGFR-2 and TGF- beta receptor activation; Aim 3. ROS generation through PDGFR-2 and TGF-2 receptor regulate SMAD2/3, Rho/ROCK, ERK1/2 and Akt signaling cascades, initiating interstitial myofibroblast migration, proliferation, and matrix synthesis. PDGF BB and TGF2-1 initiate ROS generation in vascular disease. Experiments are designed to critically examine a role for NAP(P)H oxidase and associated phox subunits in ROS generation, PDGFR-2 and TGF-2 receptor activation and signaling pathways on myofibroblast migration, proliferation and matrix synthesis in vitro and in vivo. Specifically, a role for the NAD(P)H oxidase pathway (Nox2 and Nox4 and phox subunits) will be examined in PDGFR-2 and TGF-2 receptor transduction of SMADs, Rho/ROCK, PI3K, and ERK1/2 regulation of activation of kidney myofibroblast. These studies will provide much needed insight on mechanisms of myofibroblast activation during the early stages of renal fibrosis.

Public health relevance
PUBLIC HEALTH RELEVANCE: To date, the majority of research on renal interstitial fibrosis has focused on late changes associated with matrix accumulation, with little attention on early events of myofibroblast encroachment (migration and proliferation) into the interstitium. Understanding the mechanisms of myofibroblast encroachment before fibrosis occurs could lead to new therapies in the early treatment of chronic renal disease. This application focuses on a role for reactive oxygen species (ROS) in renal myofibroblast encroachment early during the initial stages of fibrosis. Project Narrative To date, the majority of research on renal interstitial fibrosis has focused on late changes associated with matrix accumulation, with little attention on early events of myofibroblast encroachment (migration and proliferation) into the interstitium. Understanding the mechanisms of myofibroblast encroachment before fibrosis occurs could lead to new therapies in the early treatment of chronic renal disease. This application focuses on a role for reactive oxygen species (ROS) in renal myofibroblast encroachment early during the initial stages of fibrosis. __SpecificAimsTextDelimiter__ Hypothesis: Activation of PDGFR-β induces fibroblast migration and proliferation into the peritubular interstitium via Rho/ROCK modulated ROS generation and transduction of PI3-kinase/Akt, MAPK (ERK1/2) signaling pathways early during the progression of renal fibrosis. Specifically, activation of PDGFR-¿induces small GTPase Rho modulation of NAD(P)H oxidase derived ROS leading to activation (phosphorylation) of PI3K/Akt, ERK 1/2 and subsequent cell migration and proliferation. PDGF BB also stimulates autocrine TGFβ1 synthesis by myofibroblasts that may also stimulate ROS generation through similar signaling events contributing to myofibroblast migration and proliferation. a. Specific Aims: Aim 1: ROS are involved in myofibroblast interstitial encroachment early during the course of kidney fibrosis. The primary objective of this application is to determine a central role for ROS in interstitial fibroblast migration and proliferation in a model of accelerated renal fibrosis. The spatial and temporal location of myofibroblasts relative to vascular and tubular structures and the localization and activity of ROS-generating NAD(P)H oxidase of the Nox family will be examined by dual-label immunofluorescence, in situ hybridization, biochemical and in vitro cell functional assays. ROS will be blocked by diphyleneiodonium (DPI) and apocynin and antisense oligonucleotides directed to NAD(P)H oxidase regulatory subunits p47phox and isoforms of the catalytic moiety Nox2 and Nox4. The effect of these inhibitors on the temporal and spatial location of myofibroblast during progression of fibrosis and on myofibroblast encroachment will be explored. A direct effect of PDGF BB on NAD(P)H oxidase -derived ROS and myofibroblast activation will be explored after injection of the growth factor in angiotensin receptor null mice. Aim 2: ROS-induced myofibroblast migration and proliferation is a consequence of PDGFR-β activation: There is strong evidence that PDGF BB and PDGFR-¿play important roles in interstitial fibrosis (background). The role of PDGFR-¿in ROS generation will be assessed in kidney myofibroblast migration and proliferation in vitro and in vivo by examining the effect of receptor inhibitor Gleevec and antisense oligonucleotides to block signaling and interrupt NAD(P)H oxidase activity, ROS generation, and consequent myofibroblasts expansion as described in Aim 1. Aim 3: ROS generation is an intermediate step in PDGFR-β, Rho/ROCK, Akt, and ERK1/2 signaling cascades. The above aims are designed to establish roles for PDGFR-β and ROS pathways in myofibrobast migration, proliferation and development of interstitial fibrosis. Our studies suggest that PDGFR-β and ROS act through specific signaling pathways (Rho/ROCK, PI3K, and ERK 1/2) that can be correlated with myofibroblast activation, migration and proliferation. TGFβ-1 may also initiate ROS and downstream signaling through similar pathways. Our most recent studies indicate that PDGF BB and TGFβ-1 regulate Rho/ROCK modulated NAD(P)H oxidase activity. Evidence suggests that Nox-derived ROS in turn is an intermediate signal in activation of PI3K/Akt and ERK 1/2 leading to myofibroblast migration and proliferation. Myofibroblast activation and encroachment will be examined using inhibitors NAD(P)H oxidase, Rho/ROCK, Akt, and ERK 1/2 cascades at selected points and the subsequent effects on cell signaling and migration and proliferation will be determined. The effect of inhibition of Rho/Rock/ PI3K/Akt, and ERK1/2 on cell function will also be explored by selective dominant negative interference of these signal proteins activity.